Targeting DKK-1 To Prevent Osteosarcoma Metastasis

Abstract
Osteosarcoma is the most common primary bone tumor of adolescents and young adults.
Aggressive surgery and intensive chemotherapy provide long term survival to up to 75% of
patients diagnosed with localized disease, but this approach only cures 20% of patients who
present with metastasis. Numerous attempts at treatment intensification have failed to improve
this dismal prognosis, so there is an urgent need for new treatment approaches based on a
deeper understanding of osteosarcoma biology. The Wnt signaling pathway has been a focus of
investigation in osteosarcoma because of its role in normal bone biology. Canonical, β-catenin-
dependent Wnt signaling drives normal osteoblast differentiation. It has been reported that the
secreted inhibitor of canonical Wnt (cWnt) signaling, Dickkopf-1 (DKK-1) is found at high levels in
the blood of newly diagnosed osteosarcoma patients and is preferentially expressed by
osteosarcoma cells at the invasive edge of growing tumors. Inhibition of DKK-1 increases
noncanonical Wnt (ncWnt) signaling in murine osteosarcoma cells. Our laboratory demonstrated
that human DKK-1 can be detected in the blood of immune deficient mice bearing osteosarcoma
patient-derived xenografts and that a neutralizing antibody against DKK-1 increased cWnt
signaling in the primary tumor, inducing markers of differentiation and abolishing metastasis.
Taken together, these findings suggest the hypothesis that DKK-1 regulates the balance between
cWnt and ncWnt signaling in OS, affecting expression of genes important for tumor cell
differentiation and metastasis. We will test this hypothesis and generate preclinical data to guide
the implementation of treatments targeting DKK-1 in osteosarcoma patients through three specific
aims. SA1: To define the mechanism by which DKK-1 regulates the balance between cWnt and
ncWnt signaling in osteosarcoma. SA2: To optimize the timing and implementation of DKK-1
inhibition in preclinical models of osteosarcoma. SA3: To validate serum DKK-1 level as a
biomarker of disease burden and response to therapy in osteosarcoma patients. Successful
completion of this study will better define the role of Wnt signaling in OS biology, provide robust
preclinical data to inform a clinical trial of DKK-1 targeted therapy to prevent OS metastasis, and
develop a novel, noninvasive biomarker of relapse risk and response to treatment.

Public health relevance
Project Narrative An effective treatment for metastatic osteosarcoma is a critical unmet medical need. Our preclinical data demonstrate that a neutralizing antibody against the canonical Wnt signaling antagonist, DKK-1, slows primary tumor growth, induces nuclear translocation of β-catenin, upregulates markers of differentiation, and abolishes metastasis in a mouse model of osteosarcoma based on patient-derived xenografts. We propose testing a small molecule inhibitor of DKK-1 in a similar model to determine effects on both canonical and noncanonical Wnt signaling, on the growth and differentiation of osteosarcoma patient-derived xenografts, and on osteosarcoma metastasis, as well as validating DKK-1 serum levels as a biomarker of disease burden and response to therapy in patients newly diagnosed with osteosarcoma.